Discovery and engineering of novel anti-IgE disruptive inhibitors

Project Summary
The majority of allergic reactions are caused by anti-allergen IgE antibodies, which sensitize allergic effector
cells such as mast cells and basophils. In contrast to IgG antibodies, IgE binds with subnanomolar affinity to
the high affinity IgE receptor (FceRI) and persists in a receptor-bound form on allergic effector cells for months
even in the presence of high affinity anti-IgE antibody inhibitors, such as omalizumab. We have shown that
both antibodies and Designed Ankyrin Repeat Proteins (DARPins) are able to kinetically accelerate the
dissociation of IgE from FceRI through two mechanisms: a facilitated dissociation mechanism that allows
receptor-adjacent inhibitors to promote receptor dissociation and an allosteric mechanism that restricts IgE to a
conformation incompatible with receptor binding. We have developed a yeast display approach to selecting
anti-IgE inhibitors capable of disrupting receptor complexes and demonstrated our ability to select more potent
anti-IgE variants of omalizumab. In addition, we have demonstrated pathways to engineering more potent
bivalent disruptive inhibitors consisting of a disruptive anti-IgE domain and a non-competitive IgE anchoring
domain. Here we propose to apply these approaches to interrogate an anti-IgE immune library, to isolate more
potent disruptive inhibitors, to explore the mechanistic diversity of disruptive inhibitors and to develop
ultrapotent bivalent anti-IgE inhibitors compatible with future clinical development.

Public health relevance
Project Narrative IgE antibodies are central mediators of the majority of allergic reactions, resulting in significant human morbidity in the US and worldwide. Anti-allergen IgE triggers the activation of allergic effector cells, such as mast cells and basophils, through interactions with a high affinity receptor. Antibodies coat allergic effector cells through this receptor interaction and remain bound for weeks to months, sensitizing the effector cells to respond to allergens. Current therapeutics that target the IgE antibody do not impact this long-lived pool of cell- bound IgE, delaying therapeutic benefit. In this proposal, we will take advantage of new approaches that we have developed to identify rapid-acting anti-IgE inhibitors that can dissociate cell-bound IgE in minutes and that will be amenable to clinical development. These inhibitors may impact treatments for a wide range of IgE- mediated allergic diseases, including asthma, food and drug allergies, hives and chronic rhinosinusitis.